Vector Immunology Core

CORE A - SUMMARY/ABSTRACT:
The Vector Immunology Core will directly support all four projects of this program project
grant by providing reliable, consistent and standardized immunological assays. It will focus on
creating, validating and performing immunological assays to characterize B-cell and T-cell
immune responses to AAV, in mice and ferrets. It will also assay booth immune responses to
capsid and to transgene product. The core will support all four projects by characterizing B-cell
responses by transduction inhibition based NAB assays and ELISAs for capsid binding
antibodies and anti-transgene antibodies. It will develop and standardize assays for evaluating
ferret B-cell responses. It will additionally characterize T-cell responses by ELISPOT, and
cytokine profiling through both ELISA and flow-based cytokine bead assays. Finally, it will
develop flow cytometry staining protocols for the evaluation of Ferret immune responses, which
are currently not well characterized. Overall the immunology core will provide valuable data,
support and resources to all four projects within this program project grant, which will allow for
better understanding of the role the immune system in gene and cell therapies.

Public health relevance
Project Narrative Not Applicable.